Regulation of alpha synuclein release and toxicity by Rab27b

PROJECT SUMMARY This application is for F31 support for Rachel Underwood for the remainder of her PhD training. Parkinson's disease (PD) is the second most common neurodegenerative disorder that causes tremendous economic and social burden worldwide. Alpha-synuclein (αsyn) is the key protein component of intracellular aggregates termed Lewy bodies, the pathological hallmark of Parkinson's disease2. In its non-native form, αsyn is thought to propagate throughout the brain in a prion-like fashion: when released, it can be taken up by surrounding neurons to cause aggregation and cell death by inducing the misfolding of endogenous αsyn3-6. However, the mechanism that regulates the release and spread of αsyn is poorly understood. αSyn release has previously been shown to involve exosomal and non-exosomal pathways involving endosomes which are tightly regulated by a family of GTPase proteins termed Rabs8-12. Rab27b is a GTPase protein that regulates protein secretion through both exosomal and non-exosomal pathways and is highly expressed in the human brain13-15. In addition, Rab27b polymorphisms have been associated with a higher motor neuron disease risk in GWAS studies16. Rab27b transcriptional dysregulation has also been associated with other neurological disorders including Alzheimer's disease, Dementia with Lewy Bodies and X-linked dystonia parkinsonism syndrome17-19. Our data shows that Rab27b expression is increased in human PD postmortem brain tissue in comparison to age-matched healthy controls (Fig. 4). Our preliminary data also indicates that Rab27b modulates the release of αsyn in vitro (Fig. 5). Our central hypothesis is that Rab27b promotes αsyn- mediated neurotoxicity by inducing the release and spread of toxic αsyn species. The goal of this proposal is to determine the effects of Rab27b on αsyn release, spread, and paracrine toxicity. In Aim 1, we will test if Rab27b regulates αsyn release and toxicity in a paracrine tetracycline-inducible αsyn cell model, in which αsyn, upon induction with doxycycline, is released into the conditioned media (CM) and induces cell death when transferred to separately cultured neurons. We will use knockdown and dominant negative technology to test if Rab27b regulates αsyn release, clearance, and toxicity in this model. In Aim 2, we will test if Rab27b regulates αsyn aggregation, spread, and neurotoxicity in cellular and in vivo αsyn fibril based PD models. If our hypothesis is true, Rab27b may prove to be a useful research tool and a potential target for therapeutic intervention to reduce αsyn propagation in PD.

Public health relevance
PROJECT NARRATIVE Parkinson's Disease is the most common neurodegenerative movement disorder but there is currently no cure or treatment to halt disease progression. In this proposal, we will investigate the potential role for Rab27b in modulating the spread of toxic alpha synuclein, the key protein implicated in Parkinson's disease. Our studies will point to a potential mechanism to target for slowing disease progression and alleviate clinical symptoms.